COMMUNITY CLINICAL ONCOLOGY PROGRAM

The Mayo Clinic through the vehicle of the North Central Cancer Treatment Group (NCCTG) will serve as primary research base for the following CCOP's: Alton Ochsner Medical Foundation, Carle Cancer Center, Cedar Rapids Oncology Project, the Duluth Clinic, Geisinger Clinic nd Medical Center, Illinois Oncology Research Association, Iowa Oncology Research, Association Rapid City Regional Oncology Group, St. Luke's Hospitals, Sioux Community Cancer Consortium, and Toledo. We will also serve as research base for cancer control protocol activity of non-CCOP participants and for the multiple CCOP's outside of our group who contribute to intergroup cancer treatment and cancer control protocols which we lead. We will cooperate with our affiliated CCOP's in planning their program and in conducting appropriate continuing education and workshops. We will provide training and active support for their data managers and oncology nurses. We will coordinate their multidisciplinary involvement in clinical cancer research protocols. This will include evolving and maintaining standard reporting procedures for surgery, pathology, and radiation therapy. We will hold regular meetings of the CCOP's for review of ongoing research, planning future research, and for related professional activities. We will continue the rigid quality control procedures which have proved so successful in the past, and upgrade these procedures as indicated. We will constantly monitor CCOP performance not only by timely review of patient data sheets, pathology material, operative reports, and radiation therapy port films, but also by periodic randomly scheduled monitoring site visits. We will work with each CCOP participant to aid in their maturation as clinical investigators. We will assist them in developing new protocols for which they will share leadership and we will work with them in preparing publications as well as presentations for national and regional meetings. We will make every effort to provide them with justifiable pride in their participation in the National Cancer Program. A high priority over this grant period will be expansion of our control efforts into cancer prevention with incorporation of associated basic laboratory support.